Monkey Alcohol Tissue Research Resource (MATRR)

PROJECT SUMMARY
The “Monkey Alcohol Tissue Research Resource” (MATRR) is a multiple PI research resource award from
Oregon Health & Science University and Baylor University. The MATRR has been highly successful in
providing the alcohol research community access to tissue and data generated from cohorts of monkeys that
have completed a standard protocol to study voluntary alcohol self-administration. The procedure results in a
wide distribution of average daily ethanol intakes (g/kg) and the MATRR bioinformatics has established
reliable, robust categories of drinking that encompass low, binge, heavy and very heavy chronic intake
patterns. The necropsy procedure is fully refined and allows for the highest quality harvesting of all organs and
tissues in the body. Prior to necropsy, registered users and other interested parties are contacted for custom
tissue preparations, otherwise frozen and fixed tissue remain in the MATRR until requests are made through a
dedicated web resource. All tissues are accompanied by data on organismal and alcohol intake variables to aid
in rapid publication of findings. Importantly, the MATRR provides an opportunity for laboratories with specific
expertise in organ pathology, neuroscience and genomics the ability to extend their research to a primate
model with similar genetics, developmental processes, endocrinology, immunology, physiology and
neuroanatomy to humans. Thus, the MATRR is unique to the alcohol research field in promoting a translational
resource for mechanistic studies of alcohol-induced pathologies. The MATRR resource has exceeded all
expectations in terms of tissue generation, inventory control, tissue requests, tissue utilization, data analytics,
novel data generated, publications, newly funded projects and new research directions. In this renewal, we
propose to add 3 more cohorts, with an expected accumulation of tissues and data from 20 cohorts of
monkeys (total n=240 (162 ethanol, 78 control)). This has positioned the MATRR to fill experimental designs
requiring large number of individuals, for example genetic and in vivo imaging datasets. The inventory control
is aided by a unique web-based interface that also serves to administratively evaluate and act upon tissue
requests. In total, we have 226 registered users and have shipped over 3,813 tissue samples from 5,590 tissue
and data requests. With each accepted request an MTA is filed and timely progress reports are automatically
requested. In the past funding, the resource has been extremely successful in the number of publications (48
in 48 months) from 22 different laboratories at 13 unique universities or Institutes. There remain great
opportunities in further building and refining this resource. Our goal is to have the MATRR bioinformatics
integrate data across disciplines, organs and individuals to generate knew knowledge of chronic alcohol use
disorders. Finally, we acknowledge that in addition to building critical numbers for large scale data analyses,
the opportunity exists to study additional tissue (such as fetal), variations in the protocol (such as necropsy in
abstinence) and additional datasets such as sonography for liver elasticity.

Public health relevance
PROJECT NARRATIVE The Monkey Alcohol Tissue Research Resource is unique to the alcohol research field in promoting a translational resource for mechanistic and genetic studies of alcohol-induced pathologies in primates with known alcohol intake. The fully interactive website and analytics toolset, together with the structural foundation to examine reproducibility and reliability of phenotypes, is designed to dynamically interact with external research domains to advance holistic data integration for alcohol research.